Administrative Core

Abstract
The Administrative Core will be responsible for the overall management, communication, coordination and su-
pervision of the U19 program. It will monitor progress, develop and implement the project management plan,
define and monitor timelines, oversee compliance and regulatory issues and manage the data sharing plan. It
will facilitate communication among the 2 Projects and the 2 other Cores, coordinate planning, oversee scientific
and fiscal aspects of the individual Projects and Cores, and enable data management and integration. The
Administrative Core PI and CoI are also the MPIs of the U19 and will oversee the goals of the Program. Dr.
Ramilo as the U19 Contact PD/PI will also serve in that role for the Core A. Both Dr. Ramilo and Dr. Pascual as
MPIs of the program will be responsible for developmemt and implementation of a U19-wide Project Manage-
ment Plan. The Core Administrator will schedule monthly videoconference meetings of the U19 staff and of the
Leadership Committee, organize annual visits by the Scientific Advisory Board, assure institutional compliance
filings, and coordinate the annual report submission to NIAID. The Administrative Core will also work with the
Data Management and Analysis Core that will be responsible for submission of the data, metadata, and related
data analyses to the Immport.